Leptin signaling in the carotid body: mechanisms and consequences

Obesity causes multiple complications including hypertension, type 2 diabetes and sleep disordered breathing
(SDB), which contribute to cardiovascular morbidity and mortality. Obesity and its complications are linked to
increased activity of the sympathetic nervous system (SNS). The carotid bodies (CB) modulate afferent input to
the SNS and have been identified as a potential therapeutic target. CB denervation abolished hypertension and
hyperglycemia. The robust CB hypoxic chemoreflex has been implicated in respiratory instability and increased
loop gain, one of the cardinal traits of SDB. Our long-term goal is to develop novel therapeutics, which will
treat hypertension, diabetes and SDB in obesity by modulating the CB activity. During the first funding
period of the award, we discovered a unique pathway by which adipose-tissue-produced hormone leptin acts in
CB to increase the hypoxic chemoreflex and induce hypertension. Leptin interacts with the long isoform of leptin
receptor, LEPRb, on CB type I cells to activate transient receptor potential melastatin 7 (TRPM7) cation channel.
This mechanism increases carotid sinus nerve (CSN) activity and the chemoreflex, which ultimately leads to
SDB, hypertension and perturbations of glucose metabolism. We developed novel molecular approaches to
interrogate the CB leptin-TRPM7 pathway targeting Leprb gene expression, signaling via the JAK/STAT3 and
PI3K and targeting leptin resistance induced by suppressor of cytokine signaling-3 (SOCS3) and protein tyrosine
phosphatase 1B (PTP1B). The overarching hypothesis of this proposal is that, in DIO, leptin acts via
TRPM7 in the CB type I cells to increase the hypoxic chemoreflex and CSN activity leading to SNS
activation, hypertension, diabetes, and SDB, all of which can be treated by our novel TRPM7 blocker.
We will examine the role of the leptin-TRPM7 axis in CB in obesity-induced hypertension, diabetes (Specific
Aim 1) and SDB (Specific Aim 2) in mice with diet-induced obesity (DIO). We propose that leptin acts via CB
TRPM7 to increase SNS activity inducing hypertension and hyperglycemia and to augment the chemoreflex
causing SDB, which will be abolished by (A) Leprb shRNA and (B) Trpm7 shRNA applied to CB; (C) TRPM7
blocker FTY720 in a novel extended release formulation administered to the CB; and that (D) LEPRb blocker
Allo-aca and TRPM7 blocker FTY720 administered to CB will decrease CSN, phrenic, splanchnic and renal
sympathetic nerve activity. Specific Aim 3 will examine the cellular and molecular regulation of LEPRb-TRPM7
signaling in CB of DIO mice. We propose that in DIO, high leptin levels increase TRPM7 activity in CB glomus
cells (A) acutely via JAK2/PI3K signaling; (B) chronically by increasing Leprb and Trpm7 gene expression via
the JAK2/STAT3 pathway. We will employ state-of-the-art techniques including in vivo manipulation of gene
expression in CB with viral vectors, FTY720 hydrogel molecular assembly, telemetry recording, sleep studies
with quantified analysis of breathing, CB type I cell patch clamping and sympathetic nerve recording. Our
translational proposal will identify potential novel treatment of hypertension, diabetes and SDB in obesity.

Public health relevance
Obesity causes multiple complications including hypertension, diabetes and sleep apnea, which contribute to high cardiovascular morbidity and mortality. We have discovered a novel mechanism of these diseases related to signaling of fat-tissue-produced hormone leptin, which excites an ion channel TRPM7 in the carotid body, a peripheral sensor of insufficient blood oxygen. Moreover, we developed a novel treatment for hypertension, diabetes and sleep apnea in obese individuals by blocking this channel.